Continuity of the Limbic Circuit Through the Basal Ganglia

Project Summary
There is growing consensus that dysfunction of cortico-striatal circuits is a key component of
psychiatric illnesses, particularly those that involve abnormalities in incentive-based learning,
goal-directed behaviors and habit formation. These dysfunctions reflect changes in network
structure and dynamics that likely begin during postnatal development. The goal of this application
is to gain insight into the anatomic substrates underlying integration across reward/motivation,
cognitive, and motor domains in via cortico-basal ganglia circuits and the early postnatal
development of these connections. We have previously demonstrated the convergence of
motivation and cognitive circuits via the basal ganglia. In this application, we include the motor
system in addition to sampling the entire prefrontal area, creating a comprehensive fronto-striatal
connectome. Using computational tools, we will use those results to develop a probabilistic map
fronto-striatal connections. In addition, our preliminary results demonstrate that early postnatal
myelin development varies not only in frontal grey matter areas, but also between layer within
areas. We will build on these results to evaluate postnatal development of frontal inputs to the
ventral striatum. Aim 1 combines conventional tracing experiments with computational tools to
develop a complete map of fronto-striatal connections, identifying areas in which fiber from
diverse functional regions of cortex converge in the striatum. Aim 2 will examine postnatal myelin
expansion during early postnatal development compared to adult animals. Aim 3 will bring
together results from Aims 1 & 2 to determine potential changes in FC-striatal connectivity and its
relationship to cortical myelin expansion during early postnatal development.

Public health relevance
Project Narrative There is growing consensus that dysfunction of cortico-striatal circuits is a key component of psychiatric illnesses. Moreover, there is compelling evidence that points to neurodevelopmental origins for most psychiatric disorders. This study will examine the anatomical underpinnings of functional integration through the cortico-striatal neural network and changes in its circuitry during early postnatal development.